Transitions from Preschool through High School: Family, Schools & Neighborhoods

This project will continue the collection of data on children in the Panel Study of Income Dynamics (PSID) that is currently funded under NICHD Grant R01HD52646. The existing grant supported the PSID Child Development Supplement, which followed a cohort of children in PSID families who were 0–12 years of age in 1997 through three waves of data collection and focused on understanding the socio-demographic, psychological, and economic aspects of childhood in an on-going nationally-representative longitudinal study of families. By 2014, all of the children in the original cohort will have reached adulthood, and a new generation of children will have replaced them in PSID families. Our goal is to collect information in 2014 on all children aged 0–17 years in this new generation, shifting the orientation from a cohort study to one that obtains information on the childhood experiences of all children in PSID families, who will become primary respondents in the Core PSID when they form their own economically-independent households. These new data will support studies of health, development, and well-being in childhood; the relationship between children's characteristics and contemporaneous family decisionmaking and behavior; and the effects of childhood factors on subsequent social, demographic, economic, and health outcomes over the entire lifecourse for these individuals as they are followed into the future as part of PSID. The specific aims are to: (1) Design and field a new PSID Child Development Supplement (CDS) in 2014, collecting data on approximately 6,800 children aged 0–17 years through interviews with primary caregivers (typically the mother) and with older children themselves (aged 9– 17 years); (2) Collect weekday and weekend time diaries and obtain saliva samples (for subsequent genetic analysis) for all children and their primary caregivers; and (3) Process, document, and distribute the new CDS data, with scale composites, time diary recodes, and links to National Center for Education Statistics (NCES) Common Core of Data (CCD) and Private School Survey (PSS). The new CDS will provide rich data on a large, nationally-representative sample of children that includes an over-sample of African American children and a representative sample of immigrant children. CDS data will be available free of charge through the PSID Online Data Center, which provides customized extracts and codebooks using a cross-year index of variables across all waves as well as other variable-selection options.

Public health relevance
This project will design and field a new Child Development Supplement in 2014, as part of the on-going Panel Study of Income Dynamics (PSID), collecting data on approximately 6,800 children aged 0–17 years through interviews with primary caregivers (typically the mother) and with older children themselves (aged 9–17 years). These new data will support studies of health, development, and well-being in childhood; the relationship between children's characteristics and contemporaneous family decisionmaking and behavior; and the effects of childhood factors on subsequent social, demographic, economic, and health outcomes over the entire lifecourse for these individuals as they are followed into the future as part of PSID.